Data Analysis in Diagnositic Applications of Microarrays

KEY PERSONNEL. See instructions on Page 11. Use continuation pages as needed to provide the required information in the format shown below. Name Organization . Role on Project David S. Lalush, Ph.D. Bioinformatics Research Center, Candidate Department of Statistics Bruce S. Weir, Ph.D. BioinformaticsResearch Center, Mentor Department of Statistics PHS 398 (Rev. 4/98) Page 2 BB Number pages consecutively at the bottomthroughout the application. Do not use suffixes such as 3a, 3b. LL ^^ Candidate (Last, first, middle^Jf^^., Use this substitute page fortheTable of^mtents ofResearch Career Awards ^ RESEARCH CAREER AWARD